University of Washington Developmental AIDS Research Center for Mental Health (UW ARCH)

PROJECT SUMMARY/ABSTRACT
In 2015, King County WA became the first urban area in the US to achieve the WHO 90-90-90 objective, but
the past eight years have presented challenges to sustaining this success. Interactions between mental illness
and substance use, exacerbated by social vulnerabilities (homelessness, poverty) represent a syndemic that
perpetuates the HIV epidemic in King County. People experiencing homelessness face both individual- and
structural-level barriers to accessing healthcare. Individual-level factors such as psychiatric symptoms, limited
social support, and stigma impede access to care, and can be compounded by previous negative experiences
with the healthcare system. Structural barriers, such as poverty, unstable housing, limited transportation, lack
of insurance and the cost of medical care, can make traditional healthcare settings essentially inaccessible to
people experiencing homelessness who are at high HIV risk. Recognizing this reality, King County has funded
four low-barrier primary care clinics since 2018 as a key component of the EHE Plan Prevention Pillar. These
sites offer walk-in accessibility to medical care and incentives to help people engage in effective HIV
prevention strategies (e.g., pre-exposure prophylaxis (PrEP), buprenorphine, and sexually transmitted
infections (STI) control). But a tremendous burden of unmet mental health treatment needs remains a barrier to
utilization of these walk-in services. The goal of the current proposal is to adapt a single session narrative
therapy intervention to be provided on a walk-in basis in low-barrier primary care clinics where people are
already accessing care. Throughout Ontario, Canada, walk-in psychotherapy clinics offer a single session
narrative approach to create a non-pathologizing, collaborative, and competency-oriented way of addressing
the mental health needs of people in walk-in settings. The goals of the current 19-month proposal are to 1)
adapt this effective walk-in psychotherapy clinic intervention for the context of low-barrier primary care; and 2)
conduct a pilot implementation study in two low-barrier primary care clinics that are based in a community
organization that is a drop-in center for people experiencing homelessness in North Seattle. We will conduct a
mixed methods evaluation of the first 6 months of the program to assess implementation, service and patient
outcomes. This proposal represents a unique opportunity to provide services that directly address a high
priority gap in the King County EHE Plan. At the end of the proposal, we will have a contextualized and
adapted low-barrier mental health intervention which we can scale up to test in a full-scale hybrid
effectiveness-implementation trial.

Public health relevance
PROJECT NARRATIVE Persons experiencing homelessness are at increased risk of acquiring HIV but face both individual-level and structural level barriers to accessing primary care and HIV prevention services. Low-barrier primary care clinics have been established as part of the King County WA EHE Plan to provide walk-in access to primary care and HIV prevention services but are unable to address the tremendous burden of unmet mental health care needs. The goals of the current research are to adapt an effective walk-in psychotherapy clinic intervention for the context of low-barrier primary care; and conduct a pilot implementation study in two low-barrier primary care clinics that are based in a community organization that is a drop-in center for people experiencing homelessness in North Seattle.